Preclinical Psychopharmacology of Substance Abuse

Substance use disorders are a serious public health problem with medical, societal, and economic costs exceeding
$800B annually. Rates of tobacco, alcohol, and illicit drug (e.g., stimulants, and opioids) use among veterans are as high
or higher than those observed in civilian populations. Despite long-standing efforts to develop pharmacotherapies to treat
substance use disorders, few pharmacotherapies exist for nicotine, opioid, or alcohol use disorders, and there are
currently no US Food and Drug Administration (FDA)-approved pharmacotherapies for stimulant abuse. This relative lack
of pharmacotherapies for substance use disorders is likely due to a variety of factors; however, the time and costs
associated with identifying viable targets and developing effective treatment strategies has discouraged many
companies/individuals from entering this space.
One strategy to reduce the time and costs required to get candidate medications into the clinic is to leverage knowledge
about the neurobiological substrates of addiction to rationally repurpose drugs already approved by the FDA for other
indications to treat substance abuse. Given the central role for dopamine (DA) in reward, reinforcement, and addiction,
we have focused our efforts on identifying targets, such as 5-HT2C and DA D3 receptor (R)s, that are capable of modulating
the activity of the mesolimbic DA system. Indeed, strong preclinical evidence from our laboratory and others suggests that
targeting each of these receptors with FDA-approved drugs (lorcaserin [Belviq®], a serotonin [5-HT]2CR agonist; and
buspirone [Buspar®], a DA D3R antagonist/5-HT1A agonist) can reduce the abuse-related effects of a variety of drugs (e.g.,
cocaine, methamphetamine, oxycodone, fentanyl, nicotine, and alcohol). In addition, we have recently shown that the
effectiveness of these drugs to reduce drug taking are synergistically enhanced when the drugs are administered in
combination (i.e., mixtures of lorcaserin and buspirone are more potent/effective than either drug alone). Although
promising, each of these drugs have dose-limiting (off-target) effects that reduce the likelihood that these effects will
translate to the clinic.
For instance, it is important to note that doses of lorcaserin only slightly larger than those approved/required to
produce its therapeutic effects have been reported to producing feelings of “high”, “bad drug effect”, and “hallucination”
in humans; effects that are attributed to off-target actions at 5-HT2ARs. In addition to the off-target effects limiting the
clinical utility of lorcaserin and buspirone for treating substance use disorder, the relatively “dirty” pharmacology of
lorcaserin and buspirone also complicates efforts to isolate the receptor and circuit-level mechanisms that account for
these drugs (and drug mixtures) to effectively reduce drug taking behavior. Accordingly, proposed studies will combine
intravenous drug self-administration with microinjections aimed at particular brain regions to evaluate the novel
hypotheses that acute and repeated administration of fixed dose mixtures of highly selective, but experimental 5-HT2CR
agonists (CP809101) and DA D3R antagonist (VK4-116) and partial agonists (BAK4-54) will be produce a synergistic
reduction in both stimulant and opioid self-administration (Aim 1), and that these effects are mediated by a combined
activation of 5-HT2CRs in the ventral tegmental area (VTA) and inhibition of DA D3Rs in the nucleus accumbens (NAcc) shell
(Aim 2). In addition to providing important new information about the neurobiology of substance abuse, because this
strategy involves modulation of the mesolimbic DA reward pathway by targeting 5-HT2C and DA D3 Rs, this novel approach
will also guide efforts to develop a highly effective and broad-spectrum pharmacotherapy for substance (polysubstance)
use disorders. Such a treatment would have significant implications for the health and well-being of millions of veterans.

Public health relevance
Substance use disorders are a serious public health problem for which there are few effective treatments. Proposed studies build off innovative preliminary data suggesting that a combination therapy comprising fixed-doses of drugs targeting serotonin (5-HT)2C and dopamine (DA) D3Rs will produce a therapeutic effect that is greater than the effect of either drug alone. Proposed studies evaluate the effectiveness of highly selective 5-HT2CR agonists and highly selective DA D3R antagonists and partial agonists to reduce stimulant and opioid self-administration, and use local microinjections, paired with dose-addition analyses to determine whether activation of 5-HT2CRs in the ventral tegmental area combined with inhibition of DA D3Rs in the nucleus accumbens results in a supra-additive/synergistic inhibition of drug taking. In addition to providing important new knowledge about the neurobiology of substance abuse, this novel approach could result in a highly effective and broad-spectrum pharmacotherapy for substance (polysubstance) use disorders. Such a therapy would have significant implications for the health and well-being of millions of veterans.